Early Characterization of Cognitive Status and AD Risk in African American Men

PROJECT SUMMARY/ABSTRACT
Although past studies done primarily on white Americans report that men have a higher risk of mild
cognitive impairment (MCI) and more rapid progression from MCI to AD, we do not know if this is also the case
for African American men. Early characterization of cognitive status and Alzheimer’s disease (AD) risk in older
African American men is a critical unmet challenge. There have been notably few dementia studies that included
substantial numbers of older African American men. In particular, there is a paucity of neuroimaging data on
older African American men in the years prior to, and during, cognitive decline to AD. We will utilize a cross-
sectional study of older, urban African American men to characterize genetic, social, and environmental
influences on the brain and neural markers indicative of cognitive status and AD risk. My training application will
not only advance our understanding of neural changes and brain activity in older African American men,
especially those exposed to conditions that put them at high risk for AD, but how their brain health relates to
behavioral, genetic, neural, lifestyle, social, and environmental risk factors. Using observational study during the
K99 phase, I will capture brain and neural pathways to cognitive changes/decline in African Americans, while
undergoing extensive training to gain mastery of neuroimaging tools and concepts, proficiency in examining brain
image biomarkers, neuropsychological assessments, and task-based fMRI testing and analyses. In the R00
phase, we will examine the neural pathways through which social and environmental factors impact cognition
and identify individual variability that moderates their impact. Also, we will explore if social and environmental
influences are mediated by their effect on the APOE ε4 and ABCA7-80 genes to impact cognitive status and AD
risk in older African American men. Understanding the mechanisms involved in brain health and AD risk in older
African American men will improve our knowledge of how AD affects men, and which tailored interventions are
most effective for mitigating AD risk and improving cognitive function in African American men. The development
of tailored interventions is increasingly urgent given the increase in the number of African American older adults
experiencing AD and the AD-associated burdens to the individuals, families, and communities. At the end of the
K99, I will have obtained intensive training experience in structural and functional neuroimaging analytic
techniques and increased my knowledge of cognitive and genetic markers of AD. Further, I will have gained
additional expertise in aging-related chronic illness risk reduction in pre-clinical African American men. The
expertise would serve as a basis for my R00 and future independent research, where I would focus on social and
environmental determinants of health to observe and document factors that impact brain health and prevent
Alzheimer’s disease in urban African American men.

Public health relevance
PROJECT NARRATIVE We know little of the pathway to brain health in African American men, mainly because there have been notably few brain imaging studies that included substantial numbers of older African American men. My proposed research will examine cognition and AD risk markers, test diagnostic accuracy, and characterize brain health in older, cognitively healthy, urban African American men. The results will provide insights toward identifying and validating markers of brain health and AD risk in African American men—a necessary step to understanding how AD affects men and which tailored interventions are most effective for mitigating AD.